Understanding protein turnover alterations in physiological brain aging

Understanding protein turnover alterations in physiological brain aging
ABSTRACT
In mammals, physiological aging is associated with multiple molecular changes that lead to loss of cellular
homeostasis and progressive tissue deterioration. A primary and conserved feature of cellular aging is reduced
proteome integrity. Disruption of protein homeostasis machinery leads to accelerated aging in several animal
models and is implicated in human pathology. In the brain, changes in proteome integrity due to extremely slow
cell turnover promote the accumulation of damaged and potentially toxic proteins with devastating effects on
brain physiology such as cognitive impairment and synapse loss. Interestingly, age is also the strongest risk
factor for several neurodegenerative diseases, raising the question of how age-related proteostasis alterations
could become dangerous for the brain and possibly initiate the development of neurodegeneration. While
imbalances in protein homeostasis are thought to be a major cause of aging, changes in protein levels in the
aged brain are extremely small. As a result, it has been difficult to study the molecular mechanisms underlying
the age-dependent disruption of proteostasis and loss of proteome integrity. Overall, this suggests that we need
new analytical paradigms and the development of novel experimental workflows to study loss of proteome
integrity. Along this research line, by using metabolic labeling and quantitative pulsed-SILAC proteomics our
team has recently shown that in the brain, aging primarily alters the turnover of a subset of proteins associated
with neurodegenerative diseases. This suggests that specific aspects of the protein production/degradation
machinery or the complex assembly state of these proteins are predominantly affected by aging. In other words,
there are parts of the proteome that are more susceptible to age-related changes. To understand in detail these
protein turnover changes in physiological brain aging and to obtain a quantitative definition of the proteome
imbalance during aging, our proposal will: (I) study the stoichiometry of the ribosome and proteasome; (II)
measure changes in protein complex composition at the whole proteome level; (III) reveal for which protein
interaction state turnover is more specifically affected by aging; and (IV) address the effects of age-dependent
brain protein aggregation and the extent to which this extends protein lifetimes. Overall, by integrating this wealth
of information, we will greatly advance our understanding of the link between brain aging, proteostasis
impairment, and the preferential alteration of protein turnover associated with neurodegeneration. Our basic work
will provide new fundamental insights for the entire field of proteostasis impairment in aging and may ultimately
lead to new interventions to counteract the decline of the proteome during aging.

Public health relevance
PROJECT NARRATIVE Understanding the mechanisms underlying physiological brain aging is essential for developing approaches to counteract cognitive decline and develop new therapies for neurodegenerative diseases. The goal of this highly collaborative project is to use novel integrated proteomics approaches to study protein stability and protein complexes and to elucidate the fundamental mechanisms of brain aging. This study will provide foundational data to understand the alterations observed in the aged brain proteome.